Structure and function of the monotopic phosphoglycosyl transferase superfamily: Initiators of biosynthesis of complex bacterial glycoconjugates

Complex glycoconjugates play a pivotal role in bacterial survival, colonization, and virulence, and
contribute to the interactions between symbiotic and pathogenic bacteria and their human hosts. Assembly
of these macromolecules is initiated on the cytoplasmic face of cell membranes, catalyzed by polyprenol
phosphate (PrenP) phosphoglycosyl transferases (PGTs). PGTs transfer a C1’-phosphosugar from a
soluble nucleoside diphosphate-sugar to a PrenP acceptor, yielding a membrane-bound polyprenol
diphosphosugar. Our studies focus on the exclusively prokaryotic PGT superfamily with a monotopic
membrane topology (monoPGTs). Our work has previously led to the mechanistic and structural
characterization of the monoPGTs, revealing a unique reentrant membrane helix supporting the structure
of the active-site residues and substrate-binding determinants. Identification of this core fold has enabled
bioinformatic analysis of sequences from diverse bacteria where the gene encoding the PGT enables
identification of the “signature step” in a dedicated set of genes that, together, describe the glycan of the
glycoconjugate product. The proposed studies will investigate the structures and binding landscapes of
the monoPGT superfamily, and the design of biological probes will establish the fundamental knowledge
and tools needed for validating and intervening in the action of potential therapeutic targets. In Aim 1,
sequence similarity networks will guide the choice of candidates for X-ray crystallographic analysis that
will be determined with detergent-solubilized protein in the small (Sm) monoPGTs, which encodes the core
fold without elaboration. Substrate and inhibitor-liganded structures and activity analysis will elucidate the
determinants of substrate specificity. Genome neighborhood networks will inform on the presence of genes
in the operon that catalyze the biosynthesis of unusual sugars to be tested as substrates. Aim 2 will address
the pathway regulation and flux assisted by the determination of X-ray and CryoEM structures. Protein-
protein interactions will be analyzed via covariance analysis and elucidation of the structure of bifunctional
(Bi) monoPGTs, fusions of monoPGTs and glycosyltransferases, which will also define membrane
interactions and electrostatics. The binding of nucleotides to the proposed regulatory domain of unknown
function (DUF) present in the large (Lg) monoPGTs and dehydrogenases in the pathway will be tested.
Aim 3 builds on nucleoside analogs from solid-phase synthesis and non-hydrolyzable uridine
bisphosphonate-sugars (UBPs) as probes and inhibitors for the prokaryotic monoPGT superfamily. The
structure of UBPs bound to monoPGT targets in Aim 1 will inform further design and identification of
specificity determinants. Overall, these comprehensive and in-depth studies will provide a detailed
structural and functional understanding of this untapped bacterial enzyme superfamily and knowledge of
their glycoconjugate pathways and cellular function.

Public health relevance
Narrative The biosynthesis of complex sugars is fundamental to bacterial survival and to the interactions between bacterial pathogens and symbionts and their human hosts. The proposed studies will uncover how a superfamily of enzymes, which is only found in bacteria, acts at bacterial membranes to carry out an initial, critical step in complex sugar assembly. Application of chemical biology, biochemistry, structural biology, and bioinformatics approaches will provide the community a deep understanding of the structures and functions in the enzyme superfamily and its roles in the interactions between both beneficial and injurious bacteria and their human hosts.